Effect of Acamprosate on CNS hyperexcitability in alcoho

Clinical as well as preclinical studies indicate that the process for developing alcohol dependence involves a hyperglutamatergic state, which is thought to be a signal for emotional deregulations leading to craving and relapse, as well as neurotoxicity leading to cognitive impairment and loss of brain grey matter in alcoholic patients. Preclinical data indicate that acamprosate might be a useful agent to target the hyperglutamatergic state that develops during recurring episodes of withdrawal The primary aim of the protocol is to evaluate, using a randomized controlled trial, the effects of acamprosate on central glutamate/glutamine concentrations (as determined by MR spectroscopy) during withdrawal and the early post withdrawal period. In addition, exploratory biological and clinical measures are being obtained for secondary analyses.